The representational geometry of hierarchical decision-making processes

RESEARCH SUMMARY
Goal-directed behavior in dynamic, naturalistic environments depends on a hierarchy of decision-making
processes that operate at different timescales to infer context, adjust decision policy, and map stimuli to actions.
Still, the neural mechanisms underlying hierarchical decisions are poorly understood. To study these processes,
we propose a project based on recordings from large neural populations in the lateral intraparietal area (LIP),
supplementary eye field (SEF), and dorsolateral prefrontal cortex (dlPFC) of macaque monkeys performing a
hierarchical decision task. This task is a variant of the direction discrimination task with a random dots stimulus
in which monkeys classify the motion direction of the stimulus while also tracking a hidden, spontaneously
changing environment variable. Preliminary analysis demonstrates that monkeys can perform the task by
approximating a normative strategy that requires monkeys to track variables on multiple timescales: the monkey
must integrate motion evidence to make individual decisions and must integrate decision feedback and
confidence to infer the context over the span of many trials. To understand the representational and
computational mechanisms that support these dynamic and temporally multiplexed codes, I hypothesize that
hierarchical decision variables are flexibly represented in orthogonal subspaces in each population to enable
parallel computations and generalization across conditions. To investigate this, I will study the representational
geometry in each recorded region through linear decoding, dimensionality reduction, and manifold capacity
analyses. Additionally, preliminary results also demonstrate that the representations of both perceptual decision
variables (i.e., dot motion), and contextual decision variables (i.e., environment) are distributed across all
recorded regions. I hypothesize that this distributed code is maintained through task-relevant communication
subspaces, which I will characterize by identifying representational dependencies and signal latencies across
regions. Ultimately, this project will use innovative analyses and a novel, well-controlled task to provide a
comprehensive understanding of the neural mechanisms – both within regions and across regions – that underly
hierarchical decision-making processes in the primate brain. Clarifying such mechanisms has broad applicability
in our understanding of general cognition at large and may ultimately inform new diagnostic tools and therapeutic
strategies for conditions that involve abnormalities in decision-making and belief-updating, such as depression,
anxiety, and schizophrenia.

Public health relevance
PROJECT NARRATIVE Naturalistic decision-making depends on context, and to adaptively interact with an ever-changing world, agents must integrate information from individual decisions to infer dynamic contexts across different timescales and deploy appropriate strategies. The mechanisms underlying such hierarchical decision-making processes remain unknown – to fill this gap, this project studies electrophysiological recordings from a primate frontoparietal network to characterize the emergent neural representations and computations that support this behavior. By studying these neural mechanisms, we aim to support the development of new diagnostic criteria and therapeutic tools for conditions that correspond to abnormalities and decision-making and belief updating, such as anxiety, depression, and schizophrenia.